Developing and Testing a Digital Toolkit to Improve Colorectal Cancer Screening Rates in Federally Qualified Health Centers

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is a leading cause of cancer death in the United States. National guidelines recommend
that average risk people receive regular CRC screenings. Community health centers, such as federally qualified
health centers (FQHCs), provide high quality affordable healthcare to underserved populations across the nation.
Among patients treated at FQHCs, only 44% have completed a CRC screening within the recommended
timeframe (e.g., one colonoscopy per ten years). Patient navigation has proven effective for improving CRC
screening completion rates and screening quality. The effects of patient navigation are robust across
socioeconomic status and racial/ethnic group. Furthermore, extensive research has proven its efficacy in FQHC
settings. Although efficacious, patient navigation requires staffing and economic resources limiting its ability to
be widely disseminated, particularly in low-resourced settings like FQHCs. The proposed study aims to refine
and test a digital health solution, called the eNav Toolkit, designed to improve CRC screening uptake among
patients treated at FQHCs. The eNav Toolkit will be a web app that will assist with CRC screening decision
making, appointment reminders, preparation instructions/reminders, education, motivational interviewing
support, and linkage to follow up care. In order to maximize reach, the eNav Toolkit will be accessible on any
smartphone, tablet, or computer devise. For Aim 1, the eNav Toolkit 1.0 will be field tested on 10 participants.
Participants will be FQHC patients eligible for CRC screening. The field test results be applied to refine the eNav
content and improve the user-experience. The second iteration of the intervention, eNav Toolkit 2.0, will then be
field tested on a new set of 10 participants. The results from the second field test will be applied to refine and
finalize the eNav Toolkit. Aim 2 will conduct a multi-site randomized clinical trial to evaluate the efficacy of the
eNav Toolkit for improving CRC screening uptake among patients treated at FQHCs. Patients (N=400) will be
randomly assigned to one of two conditions: eNav Toolkit group (N=200) or usual care group (N=200).
Participants in the eNav Toolkit group will engage with the eNav Toolkit to assist in preparing for and completing
the CRC screening. Participants in the usual care group will receive usual care. Primary outcomes (CRC
screening completion) and secondary outcomes (CRC screening quality, follow up adherence) will be evaluated
at six months after study enrollment. Aim 3 will evaluate theoretical mechanisms of change (e.g., perceived
benefits, perceived barriers, perceived susceptibility, self-efficacy), guided by the health belief model. If proven
efficacious, the eNav Toolkit will be integrated in the electronic health record (EHR) and disseminated across
FQHCs nationwide, with the ultimate goal of decreasing the burden of CRC among patients treated at FQHCs.

Public health relevance
PROJECT NARRATIVE The proposed NCI R01 will refine and test a digital solution, called the eNav Toolkit, designed to improve colorectal cancer (CRC) screening uptake among patients treated at federally qualified health centers (FQHCs). If proven efficacious, the eNav Toolkit can revolutionize the standard care for CRC prevention in FQHCs with the ultimate goal of increasing CRC screening rates among socioeconomically disadvantaged and underserved patient populations.